Project 1 - Microglial activation in DNRAb-mediated brain pathology in mice

Project 1:
Abstract
We have shown that DNRAb, antibodies that cross-react with DNA and N-methyl D-aspartate
receptor, cause cognitive impairment when they penetrate the hippocampus. The neural injury
proceeds in two stages. First, there is excitotoxic neuronal death; second, there is microglial
activation and dendritic loss in surviving neurons. Microglial suppression by angiotensin
converting enzyme (ACE) inhibition restores neuronal integrity and cognitive function. We
propose now to study the mechanism of microglial activation and dendritic loss and the
mechanism of action of ACE inhibition. These studies have the potential to suggest additional
therapeutic targets for ameliorating cognitive impairment in neuropsychiatric lupus.

Public health relevance
Project 1 Narrative: We will study the mechanism of neuronal dysfunction and microglial activation in an antibody-mediated model of neuropsychiatric lupus, identify therapeutic approaches, and determine their mechanism of action.